Using natural language processing to determine predictors of healthy diet and physical activity behavior change in ovarian cancer survivors

ABSTRACT
Cancer survivors are a growing population in the United States; more than 16 million currently live in the US and
by 2030 this number is expected to exceed 22 million. It is estimated that more than 50 percent of new cancer
cases could be eliminated through a combination of healthy behaviors (e.g., physical activity and healthy diet);
and cancer survivors are at high risk for developing new and recurrent cancer. Unfortunately, a significant
percentage of cancer survivors are not attaining the cancer preventive guidelines of healthy diet and physical
activity. In the past few decades, a variety of telephone-based lifestyle interventions have demonstrated
effectiveness in helping survivors meet cancer preventive guidelines, however these trials are labor intensive
and expensive to deliver, limiting their potential for broad dissemination. We propose to address this hurdle by
taking advantage of recent advances in artificial intelligence to reduce the cost and maximize the impact of these
much-needed interventions. Machine learning (ML) and Natural Language Processing (NLP) are analytical
techniques that automatically learn from direct and indirect patterns in data. We propose to use machine learned
algorithms to analyze speech to aid in predicting who may be at risk of poor adoption of healthy lifestyle
behaviors. These speech data will come from the Lifestyle Intervention for Ovarian cancer Enhanced Survival
(LIVES) study, a telephone-based lifestyle intervention testing whether a diet low in fat and high in vegetables,
fruit, and fiber, coupled with increased physical activity will increase time to disease progression in 1200 ovarian
cancer survivors who have recently completed treatment, as compared to an attention control. Intervention
coaches employed motivational interviewing to elicit behavior change and all calls on the LIVES trial were
recorded with repeat assessments of diet, physical activity, patient reported and clinical outcomes. We will use
this existing and robust longitudinal data set, which pairs conversational speech data with explicit outcomes, to
achieve the following objectives. 1) Develop a ML model to identify patterns in the interactions between coaches
and their participants that signal a likelihood of optimal behavior change in diet and physical activity given the
comprehensive LIVES data set, utilizing voice recorded calls, demographics, and clinical and patient reported
outcomes collected at multiple time points. 2) Decompose the ML model in terms of “intervenable factors”, so
that participant affect, coach adherence to the intervention protocol, and other important aspects of the
interaction can be individually evaluated for their role in predicting behavior change, as well as adherence to
intervention goals. This decomposition will directly enable early and targeted adjustments to intervention plans
for individuals, reducing the cost and increasing the efficacy of intervention strategies. ML and NLP methods can
produce models that listen to a coaching conversation and automatically predict whether it will result in positive
change towards enactment of healthy lifestyle behaviors. Such predictive models would enable more efficient,
effective, and individualized lifestyle interventions, the first step towards personalized behavioral medicine.

Public health relevance
PROJECT NARRATIVE This study examines whether artificial intelligence can use speech and audio from health coaching calls to predict who is most likely to enact healthy lifestyle behaviors of diet and physical activity. This project uses previously collected data from the Lifestyle Intervention for Ovarian Cancer Enhanced Survival (LIVES) Study to 1) Develop a machine learning model to identify patterns in the interactions between coaches and their participants that signal a likelihood of optimal behavior change of healthy lifestyle and 2) Decompose the machine learning model in terms of “intervenable factors”, so that participant affect, coach adherence to fidelity protocols, and other important aspects of the interaction can be individually evaluated for their role in predicting healthy lifestyle behavior change and adherence to intervention goals.